Pathogenic Alterations of the 3D Epigenetic Landscape in Dystrophin-Deficient Skeletal Muscles and Reversal by Dystrophin Re-Expression

PROJECT SUMMARY
Lack of dystrophin (dys) and disruption of the dys-associated protein complex (DAPC) at the membrane of
skeletal myofibers are widely recognized as the main cause of sarcolemma instability, leading to skeletal
muscle loss in patients affected by Duchenne Muscular Dystrophy (DMD). In addition to its structural function,
dys has been implicated in the regulation of additional downstream cellular events, including control of the
genome integrity and gene expression. Indeed, dys-deficient muscles exhibit altered profiles of histone
modifications, gene expression and non-coding RNA, as well as features of genomic instability and nuclear
abnormalities. Chromosome conformation capture (3C)-based studies have revealed that the genome is folded
into high-order chromatin interactions. Understanding the relationship between dys deficiency, dysregulated
gene expression and altered genome topology is of special interest for the complete understanding of DMD
pathogenesis and for the evaluation of the effective benefits of therapeutic approaches aimed at replacing dys
expression in DMD boys. This proposal addresses this question by exploiting state-of-the-art genome-wide
approaches (i.e. promoter capture-HiC, ChIP-seq, ATAC-seq and RNAseq) to detect perturbations of the
epigenetic landscape and transcriptome in DMD muscles, using two complementary experimental models –
patient iPSC-based in dish model of human DMD vivo and the mdx mouse model in vivo, by the following
Aims: Aim 1. To identify alterations in high-order chromatin interactions that regulate gene expression
in DMD muscles We will identify alterations of chromatin interactions between functional and structural
genomic elements, leading to pathogenic gene expression in human (hiPSC-derived skeletal muscles) and
mouse (mdx mice) models of DMD. Aim 2. Effect of µ-dys restoration on reversal of alterations in high-
order chromatin interactions that regulate gene expression in DMD muscles We will evaluate whether
restoration of dys expression by µ-dys reverses (partly or completely) the epigenetic and transcriptional
alterations of DMD muscles identified in Aim 1. Aim 3. Bioinformatic identification and analysis of
epigenetic and transcriptional alterations in DMD muscles We will perform an integrated bioinformatic
analysis of pcHi-C, RNA-seq, ATAC-seq and ChIP-seq data to identify DMD-associated pathogenic chromatin
interactions (DMD PCI) in DMD MuSCs and myofibers, and their susceptibility to µ-dys expression. Aim 4.
Contraction-induced alterations in high-order chromatin interactions at pathogenic loci in DMD
muscles and reversibility by dys restoration We will determine the effect of muscle contraction on PCI and
gene expression at loci of pathogenic genes, within the context of dys deficiency and upon µ-dys recovery.
Understanding whether dys deficiency causes epigenetic perturbations responsible for pathogenic
transcriptional output of DMD muscles, and whether they could be reversed by µ-dys expression, will invariably
extend our knowledge on DMD pathogenesis and on the therapeutic efficacy of µ-dys based gene therapies.

Public health relevance
PROJECT NARRATIVE Duchenne muscular dystrophy (DMD) is a devastating pediatric disease caused by mutations in the dystrophin gene, leading DMD boys to wheelchair, followed by premature death within the second/third decade of their life. There is not yet a definitive cure of the disease; however, the recent entry into clinical trials of gene therapies approaches aimed at restoring dystrophin in DMD boys prompted an interest to evaluate the full spectrum of alterations caused by dys deficiency and whether they can be completely or partly restored upon gene therapy. This proposal will address this urgent issue, by investigating the relationship between dystrophin deficiency and the altered tri-dimensional genome topology and deregulated gene expression in DMD muscles, and by determining whether these alterations could be reversed upon dystrophin replacement.